Mosaic loss of Y chromosome in blood and heart failure

SUMMARY
Recent technological advances indicate that somatic DNA mutations accumulate with age and are remarkably
prevalent. The accumulation of mutations in blood cells has been associated with increases in all-cause
mortality and cardiometabolic diseases. Studies have focused on the precancerous clonal hematopoiesis state
that results from mutations in “driver” genes that recurrently mutate in blood cancers. However, this class of
mutations represent a small fraction of the total somatic mosaicism that occurs in blood. Mosaic loss of the Y
chromosome (mLoY) in blood is the most common post-zygotic mutation in humans. Epidemiological studies
have associated mLoY with all-cause mortality and a number of age-associated diseases. However, it is
unknown whether there is a causal connection between mLoY and cardiovascular disease. Here, we will
employ multiple murine models to assess the impact of mLoY in heart failure, and investigate this relationship
at a mechanistic level.

Public health relevance
NARRATIVE Loss of the Y chromosome in the blood of males increases with age, and it is associated with diminished survival and an increase risk of various diseases. However, it is not known if the loss of the Y chromosome has a causal role in age-associated diseases or whether it is an epiphenomenon of biological aging processes. We will employ novel mouse models to test whether the loss of the Y chromosome in blood cells impacts pathological cardiac remodeling.